Project 4: A Naturalistic Observation of Electronic Cigarettes and Oral Nicotine Pouch Product Use Among Adolescents and Young Adults

PROJECT SUMMARY – PROJECT 4
The tobacco product landscape changed drastically in the last decade with the proliferation of non-combustible
tobacco products like e-cigarettes (ECs) and new oral nicotine pouches (ONPs). ECs are the most used tobacco
product among adolescents and young adults (AYA) and ONP sales are climbing rapidly. The tobacco industry
has a long history of manipulating three dimensions of nicotine (concentration, form, and isomer) to improve
a product’s sensory experience and nicotine delivery. Additionally, the industry has a history of creating a product
graduation strategy whereby some products (defined along their nicotine dimensions) are “starter” for novice
users and others are “robust” for longer-term users. Further, the tobacco industry pairs their products with
specific marketing strategies designed to increase product appeal. The goal of Project 4 (P4) is to provide
a comprehensive understanding of how industry strategies across the nicotine dimensions impact
product perceptions, behaviors, and dependence among AYA in the natural environment. Participants
will be a national sample of recent initiators (within 6 months) of ECs and ONPs (N = 2000; ages 13-23).
Participants will be followed over a 2-year period; this prospective observational study will consist of surveys
every 6 months, paired with 3 ecological momentary assessment (EMA) bursts, to characterize perceptions,
use, and marketing exposures. Aim 1 will determine how ECs and ONPs are perceived over time and across
nicotine dimensions in terms of liking, risk perceptions, and social acceptability. Aim 2 will identify patterns of
escalation in use of ECs and ONPs across the nicotine dimensions. Aim 3 will determine which nicotine
dimensions are most predictive of nicotine dependence. P4 supports The Ohio State University’s Tobacco
Center for Regulatory Science overall theme “Flipping the Script”: Using the Industry’s Nicotine Playbook
to Maximize Public Health by examining the impact of ECs and ONPs, defined by their nicotine characteristics
and categorization as starter vs. robust, and perceptions of marketing in the real world. With strong ecological
validity, P4 provides naturalistic observations of youth behavior to complement the controlled laboratory
and experimental assessments that are used in P1-3. Collaboration across projects will directly inform
premarket tobacco product applications and substantial equivalence reviews, modified risk tobacco product
decisions, and product standards. P4 addresses FDA scientific domains of Addiction, Behaviors, and Marketing.

Public health relevance
The tobacco industry has historically manipulated nicotine in its products to increase their appeal and potential for addiction for the widest possible audience, including young people and non-users. They are now doing this with newer products, like e-cigarettes and oral nicotine pouches. Our center will study how these manipulations affect young people and adults, with the goal of helping the FDA develop regulations that will make these products less appealing to young people, including non-users, but not older adult smokers and smokeless tobacco users who may benefit from their use.